SOCIETAL IS A SMALL BUSINESS CONCERN FOR DOSAGE FORM DEVELOPMENT, MANUFACTURE, AND STABILITY STUDIES OF NCGC72

The scope of this contract is for formulation development of a solid oral dosage form as tablets, validation of analytical methods on drug products, manufacture of pilot batches, GMP drug product for a phase I clinical trial, and long term stability study under ICH guideline.